Dual targeting of PI3K and NOS pathways in Metaplastic BreastCancer (MBC)

ABSTRACT
Metaplastic breast cancer (MpBC) is a rare subset accounting for <5% of all breast cancers. MpBC is a significant
health challenge as it exhibits the most dismal prognosis of all breast cancer subtypes, worse than non-MpBC
triple-negative breast cancer (TNBC), with median survival rate of 8 months or less in patients with metastatic
disease. Due to a lack of druggable targets, the main therapeutic option for metastatic MpBC remains systemic
chemotherapy, despite known resistance to most cytotoxic drugs. One common molecular alteration in MpBC is
hyperactivation of the phosphoinositide 3-kinase and protein kinase B (PI3K/AKT) pathway. Additionally, we
published that MpBC also displays a gain-of-function oncogenic mutation in ribosomal protein L39 (RPL39),
which is responsible for treatment resistance, stem cell self-renewal, and lung metastasis. The mechanistic
function of RPL39 is mediated through inducible nitric oxide synthase (iNOS)-mediated nitric oxide production.
In a recently published clinical trial targeting this nitric oxide synthase (NOS) pathway with a pan-NOS inhibitor
NG-methyl-L-arginine acetate (L-NMMA), high efficacy in chemorefractory TNBC patients was demonstrated.
Furthermore, in vivo studies performed showed a significant reduction in tumor growth, associated with a
significant increase in apoptosis after the alpelisib/L-NMMA combinatorial regimen. Therefore, we hypothesize
that the NOS and PI3K signaling pathways may exert their oncogenic responses synergistically to
promote aggressive tumor growth. To test this hypothesis, Specific Aim 1 seeks to demonstrate the
therapeutic efficacy of simultaneous inhibition of NOS and PI3K pathways with chemotherapy in MpBC pre-
clinical models on primary tumor growth and metastasis. Specific Aim 2 will investigate the global and RPL39-
specific ribosome translation landscape in response to NOS/PI3K inhibition in MpBC. In Specific Aim 3, the cell-
cell interactions among tumor cells, myeloid cells, lymphoid cells, and stromal cells within the tumor
microenvironment and their role in supporting cancer niche populations will be evaluated at the single-cell level
using spatial transcriptomics, immunofluorescence, CyTOF imaging systems, and a multi-modal data analysis
model. This study thus proposes a mechanistic investigation of a combinatorial targeted approach against the
two key pathways in MpBC, identifies cell–cell interactions, and develops unique crosstalk models that will
effectively predict outcome and treatment response and complement our recently funded U01 clinical trial on
MpBC patients.

Public health relevance
Narrative: Metaplastic breast cancer (MpBC) is a rare, aggressive, highly lethal subtype of breast cancer, and the main therapeutic option for metastatic MpBC remains systemic chemotherapy, despite known resistance to most chemotherapy drugs. This proposal seeks to explore a targeted combinatorial approach consisting of simultaneous inhibition of two major pathways implicated in MpBC, the nitric oxide synthase and the phosphoinositide 3-kinase pathways, to eradicate primary tumor growth and metastasis. Our proposal will investigate the mechanisms by which these two pathways inhibit primary tumor growth and assess interactions between various cells in the tumor and its environment using specimens derived from murine MpBC models.